Core-003

Our overall vision is to develop, demonstrate, and disseminate innovative programs to achieve translational success for the benefit of human health. The Translational Endeavors Core helps the Rockefeller Center for Clinical and Translational Science (CCTS) achieve this vision by ensuring that the translational workforce is educated and skilled (Translational Workforce Development; TWD) and that investigators have access to pilot and clinical project funding to develop their novel translational research ideas (Pilot Translational and Clinical Studies Program). The specific aims of TWD are: 1. To train all members of the translational workforce in Good Clinical Practice, Protection of Human Subjects, incorporation of the views of patients and research participants in the choice of research priorities and the design of research protocols, and team science. 2. To advance the field of Research Nursing through the activities of the Heilbrunn Family Center for Research Nursing, including: a) educational activities at Rockefeller University focused on the elements in Specific aim 1 augmented by protocol-specific scientific education and training in special research-related procedures, b) leadership of national efforts to enhance the field of research nursing and its recognition as advanced specialized nursing practice through education and certification. 3. To insure that the translational workforce understands the scientific hypothesis being tested in the protocol and how it relates to the health need it is designed to address.4. To provide targeted educational programs for: a) medical students who want to participate in a year-long mentored translational research project, b) PhD and MD-PhD students, post-doctoral fellows, and basic scientists, to introduce them to the core elements in clinical and translational science, and c) junior translational scientists to help them acquire the experience, knowledge, and skills they need to transition to full scientific independence (Rockefeller Early Phase Physician Scientist Program, REPPS), d) investigators who want to translate their research findings into products to improve human health (From Discovery to Health- Enhancing Product Program), and e) community clinicians participating in research studies. The Pilot Translational and Clinical Studies Program’s specific aims are: 1. To encourage high quality translational research projects, especially those that contain: a) a community-based research component, b) children or the aged, c) minority, underserved, or health disparity populations, d) low socio-economic populations, e) patients and community clinicians in setting the research priorities and designing the study. 2. To expand translational science by encouraging basic scientists to explore new translational or disease-related aspects of their research programs. 3. To support research Clinical Scholars and other early-phase translational scientists.4. To encourage the creation of transdisciplinary or community engaged scientific teams. To accomplish these aims, the CCTS will implement a broad, integrated educational program for the translational workforce and trainees, and a robust pilot project program to encourage and support translational studies.